Johns Hopkins University Site Consortium - Adolescent Medicine Trials Network for HIV/AIDS Interventions (ATN) Operations and Collaborations Center (UM2 Clinical Trial Optional)

ABSTRACT Johns Hopkins University
Youth (ages 13-24) living with HIV comprise one fourth of new HIV diagnoses in the United States (U.S.) and
have the lowest rates of engagement and retention in care and prevention, initiation of antiretroviral treatment,
and virologic suppression, increasing the risk of disease progression and transmission, with important public
health implications. These disparities threaten the U.S. government's target of ending new HIV infections by
2030, outlined in the Ending the Epidemic Plan for America (EHE). The Adolescent Trials' Network (ATN), the
only youth-targeted HIV network, combines expertise in clinical care and research to develop optimal
approaches to addressing the challenges facing youth at-risk for and living with HIV. Located in Baltimore,
Maryland, an EHE jurisdiction, the Johns Hopkins Adolescent Young Adult Research Equity for Adolescent
Care and HIV Consortium (JHU AYA REACH) has a long-standing overarching commitment to mitigate the
impact of HIV and improve health outcomes for AYA at-risk and/or living with HIV via a clinical research
program focused on integrated, cross-disciplinary studies of AYA-centered novel interventions (e.g.,
biomedical, management, strategy) that span from bedside to community. Synergies between clinical care
research, public health, and community, centered on AYA, substantially enhances relevance, improves
feasibility, optimizes success, and amplifies impact. The JHU AYA REACH infrastructure aims to optimize
these synergies ultimately uniting the scientific rigor (clinical trial design and implementation, outcomes,
interventions) with clinical expertise and real-world understanding, ensuring that research questions/answers
are relevant, implementable, and scalable. Led by Drs. Agwu and Sanders (Co-Project Leads), the JHU AYA
REACH, has a longstanding and productive involvement in clinical trials' networks and cohorts (ATN,
International Maternal Pediatric Adolescent AIDS Clinical Trials' Group [IMPAACT]) with much of that
involvement overseen by Westat and JHU AYA REACH is home to a prolific group of diverse, collaborative
multidisciplinary investigators. The consortium includes an established network of community and
governmental partners increasing the likelihood of effective translation of the research outcomes. For this
application, we will: (1) Develop and conduct science that incorporates innovative approaches to addressing
the critical scientific gaps and questions impacting AYAs, particularly Black and Hispanic/LatinX AYA, at-risk
for or living with HIV; (2) Coordinate with diverse entities, affiliates, and stakeholders across the institution and
community, including AYAs, to ensure timely, accurate, and effective engagement in the proposed research;
and (3) En
sure that AYA voices and lived experiences are central to the research activities of the JHU AYA
REACH through active and purposeful involvement of AYA through the Youth Advisory Board (YAB) and other
forums. The JHU AYA REACH's expertise, experience, and goals directly align with the ATN enriching the
capacity to develop and conduct innovative and impactful interdisciplinary AYA-specific research, providing
added overall value to the proposed ATN.